Mesh electronics for understanding space encoding in the amphibian brain

PROJECT SUMMARY/ABSTRACT
Many animals rely on spatial cognition for daily survival in order to recognize familiar places and process movements
through or between locations. A variety of space-encoding cells in the hippocampus are important for spatial behaviors
in mammals. However, neural encoding of space remains uncharacterized in other vertebrate taxa, including
amphibians, whose simpler brain structure suggests alternative mechanisms of encoding space. The severe gap in our
understanding of how the simple amphibian brain functions stems, in part, from difficulty in recording neural activity.
The amphibian brain exhibits a greater degree of movement within the skull than other vertebrates, which could lead
to an instability of electrophysiology recordings in moving animals using conventional implantable neural probes.
Recently our labs have developed 1) a new form of electronics with tissue-like flexibility and stretchability for
chronically stable neural recording with single-neuron resolution, and 2) cane toads as a model to study the neural
basis of amphibian spatial behaviors. We propose to develop stretchable mesh electronic neural probes for in vivo
electrophysiological recording of single neurons in the medial pallium, the proposed homolog of the mammalian
hippocampus, in freely moving toads. We hypothesize that the medial pallium contains neurons that fire with spatial
specificity, similar to place cells or head direction cells in the mammalian hippocampus, but with lower resolution and
high correlation with specific environmental features (e.g., borders). We predict that single-cell activity of some
neurons in the medial pallium, which is measured by mesh electronics in freely moving toads, will be correlated with
spatial position within a behavioral arena, while neurons recorded from another region will not. Prior to recording
from the medial pallium, we will establish mesh recordings in the optic tectum, a region easily accessible on the dorsal
side of the brain which has been a target for previous electrophysiology studies. We will validate the results with
rigorous statistical analyses and comparison of neural recording data with immunohistological imaging of brain slices.
Understanding how amphibians learn and encode spatial information will reveal either alternative mechanisms for
learning and encoding of spatial experiences or which paradigms are ancestral features of vertebrate brain function
and how neurobiological principles of space coding might generalize across vertebrate taxa. Importantly, our approach
will result in the development of chronically stable recording techniques in brains with large movements in the skull.
This advance will be a valuable research tool for expanding the scope and possibility of electrophysiology studies in
other animals. Successful completion of this project will allow us to obtain proof-of-principle data elucidating
fundamental questions relating neuroanatomy to neuronal functions, which is crucial for future R01 applications.
Furthermore, establishing a recording protocol in cane toads will allow for other aspects of neural function in
amphibians, a research area that has thus far been limited due to technological constraints. In summary, our proposed
research will help elucidate the core coding principles in the relatively simple amphibian brain and reveal how these
principles for spatial encoding might generalize across vertebrate taxa.

Public health relevance
PROJECT NARRATIVE Understanding how spatial information is encoded in non-mammalian taxa is crucial to revealing how neurobiological principles of cognition generalize across vertebrates, but tools to execute stable neural recordings in amphibians that can compensate for the large amount of brain movement within the skull have been limited. To address these issues, flexible and stretchable mesh electronics will be used to record and manipulate neural activity with single-neuron resolution in key brain regions related to spatial encoding in cane toads as they explore a simple spatial arena. This project will create a valuable tool for the chronic recording of neural activity in mobile brains for the broader neuroscience community and will elucidate the core coding principles in the relatively simple amphibian brain, which will broaden our fundamental understanding of space coding and other key cognitive functions.